GSA OASIS TASK ORDER TITLED "NIH/NHLBI RESEARCH AND SCIENTIFIC POLICY SUPPORT AND CLINICAL RESEARCH ORGANIZATION (CRO) MANAGEMENT".

nsuring the availability of consistent support is crucial for the success of the RECOVER initiative. With the adult cohort nearing completion of enrollment and many tests being conducted, data being analyzed and published, it is essential that NIH has the necessary resources to maintain the quality of research and integrity of the data through the end of the performance period in 2025. The pediatric and autopsy cohorts are also in the midst of enrollment and require additional oversight and support to ensure that enrollment goals are achieved within the study timeline.